Extensive multiplexing of protein nucleic-acid interactions to comprehensively study gene expression regulation from chromatin to mRNA degradation

Although every cell in the body contains the same DNA sequence, mammalian organisms consist
of thousands of cell types defined by distinct gene expression programs. How molecular
components, including DNA, RNA and proteins, act to control gene expression is a long-standing
question. The model whereby regulatory factors diffuse through the nucleus and engage with their
cognate DNA and RNA targets through high affinity interactions cannot explain many of the
quantitative features required for gene regulation. The observation that many transcription factors
and chromatin regulators organize into higher-order structures within the nucleus may explain the
quantitative aspects. Yet, we don’t know (i) the DNA binding and spatial organization of most
regulators, (ii) what specific components are present within these compartments, and (iii) what
role spatial organization plays in gene regulation. The challenge is that we lack methods to
measure combinatorial organization of these molecular components and the ability to disrupt
compartmentalization and measure its impact on gene regulation. To address this, we are
developing cutting-edge genome-scale methods that allow us to measure multiplexed protein
binding and spatial organization of DNA. Specifically, we will create genome-wide maps of
hundreds of DNA binding proteins including transcription factors, chromatin regulators, histones
(with various modifications) and RNA polymerases. We will then explore the RNA-dependence of
regulatory proteins localization by comparing spatial organization in the presence and absence of
RNase treatment. Finally, we will then disrupt formation of specific regulatory compartments
(using Locked Nucleic Acid and/or CRISPR approaches) to understand possible mechanisms of
spatial organization in regulation of specific genes. Our results will provide novel capabilities and
a framework for understanding how DNA, RNA, and protein molecules work together in 3D space
to efficiently regulate gene expression.

Public health relevance
We expect that the ChIP-DIP technique developed and applied here will empower individual researchers in the biological and medical communities to generate detailed functional genomic datasets in specific biological, developmental, and disease contexts that are comparable in breadth with those provided by the ENCODE project, at a tiny fraction of the cost. More generally, we anticipate that it will be widely useful and will lead to transformative and critical insights into gene regulation and human disease.